A systems biology investigation of the interplay between gut microbes and blood metabolites in the development of malarial anemia

Project Summary/Abstract
Anemia causes significant disease worldwide, and disproportionally affects Africans and African-Americans.
Among the top causes of anemia are nutrient deficiency, hemoglobinopathy, and the parasitic disease malaria.
Malarial anemia is multi-factorial and is affected by host physiology, including blood metabolite levels and gut
microbiota composition. While gut microbes are known to affect hematopoiesis, there is very little data on the
role of gut microbes in the development or recovery from different types of anemia, and this is therefore a
worthwhile area of investigation. Systems biology offers the opportunity to decipher complex processes and
computationally identify biological factors that are associated with the onset or recovery from anemia. The goal
of this research is to determine how blood metabolites and gut microbes are linked to the hematological changes
that occur during malarial anemia. The central aims of this research project are to 1) identify associations
between blood metabolites and gut microbes in the development of malarial anemia and 2) determine the extent
to which bacterial translocation and bacteremia are associated with hematological changes in malaria. Both
aims will involve the analysis of samples from longitudinal infection studies of nonhuman primates infected with
the malaria parasite Plasmodium. High-throughput `omic technologies such as metabolomics and
metagenomics, computational approaches such as data integration and network analyses, and detailed
immunofluorescence studies on tissue will all be used for the multi-omic profiling of host and commensal
microbial factors in the context of malarial anemia. The applicant, Dr. Regina Joice Cordy, is a junior faculty
member at Emory University and has a background in parasitology, host-pathogen interactions, and
computational biology. She also has experience in managing the logistics of a large transdisciplinary multi-
institutional systems biology program. Building upon her current skills, and adding new complementary skills in
metagenomics and network analysis, experimental hematology, and immunofluorescence imaging, Dr. Cordy
aims to identify specific blood metabolites and/or gut microbes that are associated with the development of, or
recovery from malarial anemia, toward the goal of identifying prognostic biomarkers and metabolic or probiotic
drug targets. Prof. Mary R. Galinski of Emory University will serve as the Primary Mentor and Dr. Cordy will have
access to a state-of-the-art infrastructure based at Emory for performing longitudinal multi-omic systems biology
studies in nonhuman primates. Further, Dr. Cordy has assembled a diverse team of mentors, collaborators and
career advisors who will provide mentorship and advising for her research and career development objectives.
The experience gained through the proposed training and research experience will prepare Dr. Cordy for
initiating a long-term research program focused on investigating the systems biology of anemia.

Public health relevance
Project Narrative Anemia causes significant morbidity and mortality worldwide, and the parasitic disease malaria is one of the leading causes of anemia globally. We aim to use systems biology approaches, including large multi-omic datasets from longitudinal nonhuman primate experimental infections, to identify blood metabolites and gut microbes that are associated with the onset, severity and recovery of malarial anemia. This research aims to identify novel drug targets for metabolic and/or probiotic therapies for anemia in both malarial and non-malarial contexts.